Medical Oncology Fellowship Program

The Medical Oncology Fellowship Program at the National Cancer Institute provides a unique opportunity for physicians interested in academic careers to develop and integrate both their clinical and basic research interests. The clinical portion of the Fellowship consists of primary responsibility for the clinical care of inpatients and outpatients with a board spectrum of adult malignancies. During the first clinical year, there is an emphasis on exposing fellows to the basic science and clinical oncology. During the research years, the fellow will join one of the several hundred available investigators within the National Cancer Institute to acquire the skills necessary to become an independent biomedical investigator. The NCI works hard to guarantee at least two years of protected research time to all of its medical oncology fellows. During the first year of training, fellows devote 100% of their time to clinical training in inpatient and outpatient care at the NIH Clinical Center (NIH-CC), Georgetown University's Lombardi Comprehensive Cancer Center and the MedStar Washington Hospital Center. This ensures that fellows undergo comprehensive clinical training and extend their experience with a wide spectrum of human cancers. Training in clinical diagnostic procedures such as bone marrow examination, thoracentesis, and paracentesis is a routine part of the first-year experience. The remaining time in the second and third years is protected time for research in any of the NCI Clinical Teams or any NIH laboratory. All fellows are expected to actively engage in a hypothesis-driven research project(s) in a clinical, translational, or basic science. The NIH-CC emphasizes the development of new approaches to the treatment of cancer and its complications. Current areas of clinical emphasis include prostate cancer, ovarian cancer, renal cell carcinoma, lymphomas, Hodgkin's disease, chronic leukemia, new drug testing, stem cell transplantation and AIDS, and its associated malignancies. Patients with AIDS and AIDS associated malignancies constitute approximately 5% of the total patient population; nearly all these patients are involved in studies of experimental antiretroviral compounds and chemotherapy. The Medial Oncology Branch also has a joint Hematology/Oncology Training Program in collaboration with the Hematology Branch, National Heart, Lung, and Blood Institute (NHLBI) since significant number of medical oncology fellows pursue additional training in hematology. This program combines hematology and medical oncology into a series of clinical rotations encompassing 18 months of fellow's training. Fellows whose principal interest is hematology have a primary appointment in the NHLBI and their chief clinical exposure is in clinical hematology but includes six months of clinical oncology in the Medical Oncology Branch, NCI. Fellows who have a primary interest in medical oncology have their appointment with the NCI and will have an additional six months of hematology rotations. The first 12 months of training are exactly like that for medical oncology-alone. In the second year they undertake an additional 6 months of clinical hematology that usually includes the following: 2 months of inpatient hematology (NHLBI), 1 month leukemia service (Johns Hopkins Hospital), 2 weeks transfusion medicine, 6 weeks consult hematology and coagulation, and 1 month rotation at the Washington VA Hospital. Following completion of this 18-month clinical period, the fellow does laboratory or clinical research for up to 4 years of fellowship along with continued outpatient clinical duties. Offered throughout the Program are lectures, research seminars, conferences, journal club, teaching rounds and conferences relevant to clinical oncology and cancer research. Most of these are organized specifically for medical oncology fellows. These include a core curriculum lecture series in clinical oncology, which meets once a week throughout the year, andoffers lectures by members of the senior staff across the spectrum of issues in neoplastic disease. Fellows are responsible for preparing case presentations and lecture material. In addition, there are 10 to 15 research seminars and lectures given per day throughout the NIH; these are advertised in a weekly announcement and are regularly open to the entire NIH community. It is expected that each fellow's research activities will lead to at least one abstract presentation at a national meeting and one or more peer-reviewed publication.